Theoretical and Physiological Basis of Priority Maps in the Frontal Eye Field

Project Summary
Each movement of the eyes is the outcome of a competition between the stimulus at the fovea, the target of the
movement, and other potential targets. The frontal eye field (FEF) is thought to maintain a map of priority for
saccadic eye movements, combining information about the salience of stimuli with their behavioral relevance to
guide the flow of eye movements. The objective of this work is to understand how priority maps form in FEF. The
overall hypothesis is that FEF neurons form these maps by learning to anticipate saccades and as a result,
integrate a wide range of sensory, motor, and cognitive signals into a singular representation that reflects
expectations about the timing and probability of saccades. Recently, we developed a novel simulation of
associative learning during natural oculomotor behavior that permits measurement of the visuomotor properties
of neurons that arise from a given learning goal. The first aim is to use this simulation to determine if FEF neurons
in silico develop visuomotor properties like FEF neurons in vivo when they learn to anticipate saccades. We will
simulate several FEF networks, each designed to learn distinct goals related to oculomotor behavior and
characterize the properties that develop in each. Our preliminary data suggests that when neurons anticipate
movement goals, their visuomotor properties capture many important characteristics of FEF neurons.
Specifically, the modeled neurons develop dual visual- and movement-related responses, their visual sensitivity
shifts across space around the time of saccades, and they respond more vigorously when visual stimulus in their
receptive field is the target of a saccade. Furthermore, both the visual and movement responses are relatively
early, consistent with a short-latency subpopulation of FEF neurons. The second aim is to assess a prediction
of the model, that expectations about saccades are encoded in FEF visual responses. To do this, we will record
single-neuron activity in the FEF of monkeys while they complete blocks of a delayed saccade Go/NoGo task.
The model predicts that manipulations of the probability or time at which a saccade follows a visual stimulus will
modify subsequent visual responses. The third aim is to determine how reward affects the visual sensitivity of
FEF neurons. We will alter the reward contingences in the Go/NoGo task to test if FEF neurons encode reward-
related information or if their apparent sensitivity to reward is at the service of encoding movement-related
information. The outcomes of the second and third aims will be applied to improve the model as needed and
generate new predictions. Collectively, this work will establish how the visual responses of FEF neurons are
shaped by experience about saccades and reward and provide a rigorous basis for understanding the formation
of priority maps in FEF. This basic knowledge is a prerequisite to identifying the source of deficits in saccadic
behavior in disorders like schizophrenia and autism. Through training opportunities during this project, I will
develop the skills necessary to transition from computational to experimental research.

Public health relevance
Project Narrative Our eyes capture the world around us like a camera, but not all pictures are worth taking, and it is the photographer who decides which parts of a visual scene are worth capturing. This project uses modeling and recording of nerve cell activity to understand how the brain acts as that “photographer” to prioritize which objects in the visual field are worth looking at. Knowing how the brain accomplishes this will aid in characterizing its disruption in complex disorders like schizophrenia and autism.